Understanding the impact of the Affordable Care Act on cancer treatment and outcomes for adolescents and young adults (AYA)

Adolescents and young adults (AYAs; diagnosed with cancer at ages 15-39 years) have lagged
in improvements in cancer survival seen among younger and older populations. A major barrier
to improvement in cancer outcomes is the lack of access to healthcare, historically associated
with the high rates of uninsurance in this age group. Uninsurance also drives the
sociodemographic (racial/ethnic, socioeconomic, urban-rural) disparities in cancer survival,
overall and among AYA populations. The Affordable Care Act (ACA) provides an option for
states to expand Medicaid coverage to adults with income ≤138% of the federal poverty level.
Expanding Medicaid coverage can reduce uninsurance in young adults, as well as in
adolescents via extending coverage to their adult parents. To date, there has been no prior
study to examine the impact of the ACA Medicaid expansion on increasing access to cancer
care or its association with early detection, timely treatment, and survival improvement in AYAs.
We will utilize the National Cancer Database (NCDB) to examine a cohort of ~246,000 AYAs
diagnosed with cancer between 2010 and 2016 across all US states and D.C. The national AYA
cohort will allow a rigorous, quasi-experimental approach to determine the net effect of the ACA
Medicaid expansion on the timeliness, outcome, and equity of cancer care for AYAs with the 8
most common cancers (female breast cancer, testis cancer, melanoma, colorectal cancer,
thyroid cancer, cervical cancer, Hodgkin lymphoma, and non-Hodgkin lymphoma). The NCDB
captures >80% of all new AYA cancer cases in the US, and will enable us to generate
nationwide estimates of the impact of the ACA Medicaid expansion on cancer outcomes,
including time to treatment initiation and survival. In addition, we will evaluate the cohort pre and
post Medicaid expansion by sociodemographic factors (race/ethnicity, socioeconomic status,
urban-rural) to underline disparate outcomes. This research will inform policy interventions for
cancer control toward reducing disparities in AYA cancer.

Public health relevance
Adolescents and young adults (AYAs) with cancer (ages 15-39 years) are a unique population who have lagged in survival gains seen by those older and younger. This study will provide the first evidence of whether the Affordable Care Act Medicaid expansion improves the timeliness and survival of cancer care among the AYA patient population, overall and by groups further at risk for disparities in cancer outcomes. This study will inform future policy interventions aimed at increasing access as a means to reduce disparities in AYA cancer outcomes.